Molecular Noise, Transcription Errors and Heritable Phenotypic Change

DESCRIPTION (provided by applicant): The overall goal of this research is to define the origins and the consequences of errors in information transfer from DNA to protein in the perpetuation and perturbation of genetic regulatory networks that generate stable phenotypes in cellular lineages of Escherichia coli, e.g. bistable switches. Bistability has been proposed as a mechanism for decision-making and memory in gene circuits, relying on positive feedback loops between transcription factors of low abundance. The central hypothesis of this proposal is that transient errors in the information transfer from DNA to protein contribute to protein fluctuation (molecular noise) and that these errors can cause heritable non-genetic phenotypic heterogeneity, when associated with bistable regulatory networks. Specifically, we propose that the transient disappearance of functional protein (in our case, a repressor that negatively regulates the expression of other genes) due to errors in transcription, translation, or protein folding can produce a heritable phenotypic change in genetically identical cells growing in the same environment. To capture and quantify transient events from such errors, two well characterized bistable systems will be used, the lactose operon and the lambda switch. In these systems, the stochastic switching from one phenotypic state to the alternative phenotypic state will be an indicator of molecular noise. This work will illuminate the fundamental cell/molecular biology of protein-based epigenetic switches, which are likely to be critical to many fundamental aspects of biology and medicine including cancer, aging, prion genesis, and pluripotency of stem cells.

Public health relevance
PUBLIC HEALTH RELEVANCE: To generate diversity, cells run specific programs orchestrated by specific protein regulators. Sometimes the making of these proteins is erroneous, leading to dysfunction of the program, and loss of cellular identity. Our study aims to understand the origin and consequence of these errors on these protein regulators. To generate diversity, cells run specific programs orchestrated by specific protein regulators. Sometimes the making of these proteins is erroneous, leading to dysfunction of the program, and loss of cellular identity. Our study aims to understand the origin and consequence of these errors on these protein regulators. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Phenotypic inheritance relies on the correct transfer of the genetic (DNA) and epigenetic (expression state) information. It is well established that DNA alteration can heritably change the phenotype of a cell, but what is less clear is what triggers epigenetic change. Seminal work in bacteria has highlighted the importance of genetic networks in epigenetic inheritance [1, 2]. To generate stable phenotypic diversity in a population, cells with identical genomes can be differently programmed by transcription factors connected in a positive feedback loop, allowing the stable expression of two alternative phenotypes [2-4]. Regulatory proteins associated with these molecular switches are often present in low numbers and therefore, subject to fluctuation or "molecular noise" [5, 6]. Therefore, the strategy used by a genetic network to control levels of its key regulators is fundamental to the understanding of the potential sources of dysregulation. Molecular noise in gene expression is universal and arises as a result of the stochastic nature of transcription and translation [7- 14] and can directly perturb the behavior of genetic-regulatory-networks (GRN) generating phenotypic diversity [5, 15]. The aim of this study is to investigate the role of transient errors in information transfer (transcription, translation, or post-translational modification errors) in the dysregulation of bistable genetic networks leading to heritable change in phenotype. We hypothesize that random and transient errors in the information transfer from DNA to protein can produce fluctuations or "molecular noise" in a transcription factor population that, when associated with bistable networks, trigger heritable epigenetic change. This process represents a novel mechanism of epigenetic control which is likely widespread in nature [16]. Thus, these transient errors have the potential to generate stochastic and heritable phenotypic change in a clonal population as observed, for example, in bacteria susceptibility to antibiotics [17], in human cancer or stem cell differentiation [18-20]. We propose to elucidate the molecular basis of this novel mechanism of epigenetic inheritance using classical bistable switches in E.coli, the lambda genetic switch [21] and the Lac operon [22]. To study the contribution of information transfer errors on the generation of heritable phenotypic diversity, the following specific aims will be pursued: 1. Isolate mutations that affect transcription fidelity and study their effects on epigenetic inheritance. Our data show that infidelity of transcription increases heritable phenotypic change in the Lac bistable switch [23]. We will (a) isolate new low- and high-accuracy mutants of RNA polymerase and determine their effects on epigenetic change in the Lac bistable switch; (b) test deletions of candidate genes affecting transcription fidelity for their ability to perturb the Lac bistable switch; and (c) investigate the effect of chemical perturbation of RNAP in promoting epigenetic change. These results will support our finding that epigenetic change can result from transcriptional errors and help elucidate the mechanisms governing transcription fidelity in vivo. 2. Determine whether transcription errors can directly trigger epigenetic change. Alteration of transcription fidelity can have pleiotropic effects on cell physiology. To show that our epigenetic switching is directly affecting the LacI repressor: (a) We will construct a lacI repressor gene prone to transcription slippage and measure the switching frequency from one state to the other and (b) We will estimate the frequency of transcription errors in wild-type and in our lacI slippage strain by cloning cDNA from lacI mRNA and correlate these frequencies with the switching frequency. These results will provide the demonstration that transcription errors in a gene encoding a transcription factor involved in a bistable switch can produce heritable phenotypic changes and probe particular sequences prone to transcription errors in vivo. 3. Study the role of proteostasis in epigenetic inheritance. The lambda switch is composed of two antagonistic repressors CI and Cro, allowing for two different heritable phenotypes based on gene expression states. Strains carrying this switch show stochastic epigenetic change at low frequency. One of the main design features of this genetic switch is that its key regulator CI is poorly translated suggesting that molecular noise in this case may arise from post-transcriptional errors in information transfer. We will investigate the origins of stochastic switching in the cI-cro network by probing genes involved in post-transcriptional synthesis. These results will illuminate the importance of protein quality control systems in epigenetic inheritance and highlight design differences in the architecture of bistable genetic networks that contribute to phenotypic stochastic switching.